Development and Evaluation of Computerized Chemosensory-Based Orbitofrontal Networks Training for Treatment of Pain (CBOT-P)

PHASE I/II (FAST/TRACK) ABSTRACT
The Development and Evaluation of Computerized Chemosensory-Based Orbitofrontal Networks
Training for Treatment of Pain (CBOT-P) is a project to develop an effective, scalable, user-friendly, and home-
based neuromodulatory platform for broad-spectrum treatment of chronic pain conditions with associated
negative affect and cognitive impairments. Chronic pain (CP) affects 1.5 billion people globally, and causes
severe human suffering, disability, and high financial burden. Clinical and neuroscience studies show that CP
over time leads to shrinkage in the prefrontal cortex (PFC) regions and their deep brain connections critical to
emotion, motivation, and cognitive functions. As a result, more than 40% of CP patients suffer negative affect
(i.e., anxiety and depression), cognitive and decision-making problems and reduced drive. Chronic pain with
negative affect (CP-N) is more debilitating, harder to treat, costlier to payers and significantly more associated
with opioid use, overdose, and deaths. In a stakeholder value canvassing exercise CP sufferers and pain
doctors unanimously desire new non-invasive, home-based, safe, and effective interventions that can reduce
pain severity by more than 10%, suggesting that current treatments have limitations. Anterograde and
retrograde anatomical tracings have been used to demonstrate direct (monosynaptic) anatomical connection
between the OFC and the descending inhibitory pain nodes at the midbrain periaqueductal gray matter (PAG).
Transition to CP is marked by weakened modulation of the PAG-descending inhibition. Evon Medics, a small
business specializing in olfactory neurotherapeutics, developed an innovative chemosensory-based
orbitofrontal cortex (OFC) stimulation device, called CBOT-P, for home use, to increase OFC plasticity and
effect OFC-induced regulation of pain and negative affect. We now plan to refine this product for broad pain
conditions and quickly make it available to the population. OFC is the part of the prefrontal cortex that plays
key roles in multisensory integration, affect regulation, and decision-making. The lateral OFC, which is
consistently activated by pain, is connected to other cortical brain regions that process pain; and the medial
OFC, which networks with medial temporal affect networks, is engaged by mindfulness therapy for pain and
plays important role in positive affect and drive. Unfortunately, CP and opioid analgesics are associated with
OFC shrinkage, which amplifies pain through increased negative affect (NA) and cognitive impairment. The
success of CBOT-P in acute relief of NA and pain in our pilot studies is not surprising because single-pulsed
electrical stimulations with OFC-placed electrodes acutely relieved NA in humans in invasive deep brain
stimulation, and experimentally induced stimulation of the OFC in animal models and humans activates the
PAG to reduce pain sensitization. The CBOT-P uses Evon’s proprietary regimen of 10 odorant phytochemicals
to stimulate the secondary olfactory cortex (i.e. the OFC) repetitively, with established micro-controller-
regulated stimulation parameter settings that maintain persistent activation of the OFC and medial temporal
regions, without habituation; paired with digitally-administered olfactory psychophysical training tasks that
activate same regions, for synergistic effect on long-term neuroplasticity changes that prevents CP-induced
shrinkage. As a second mechanism of action, the olfactory stimulants were fortified with proprietary
components, such as beta-caryophyllene (BCP), a selective endocannabinoid-2 receptor agonist, which has
strong anti-inflammatory and antinociceptive effects, and scalable for acute positive affect.
In the Phase I of this Fast-Track SBIR application, we will (a) configure CBOT-P regimen and
stimulation parameters for faster onset of mood elevating and analgesic effects, focusing on Chronic Low Back
Pain populations and (b) establish its neural mechanism of action through target-engagement studies of OFC
activity and functional connectivity with other pain regulating regions at baseline. In Phase II, we will perform a
powered randomized trial of the refined CBOT-P from Phase I, compared to sham CBOT in CLBP, to
determine its short- and long-term effectiveness on Pain, Affect, Cognition and cortical brain Structure (PACS),
long-term safety, and indications. We will also collect user experiences to help refine a final marketable CBOT
product, enter the FDA breakthrough designation program for pain that would lead to Medicare/Medicaid
reimbursement, engage a wider network of pain stakeholders, and establish marketing for commercial
success. Project success will be enhanced through strong collaborations between Evon Medics, Johns
Hopkins (JHU) Pain Center, Howard University investigators, community pain providers and collaborating
manufacturers. To the best of our knowledge this will be the first home-based combinatorial digital-
chemosensory neuromodulatory product for stimulation of deep brain regions for CP management.

Public health relevance
NARRATIVE In contrast to acute pain, which is a common and an often-transient experience necessary for survival, chronic pain is a detrimental pathological state that drives changes in the orbitofrontal cortex (OFC) and associated prefrontal (PFC) brain regions – needed for cognitive functions, modulation of the descending inhibitory pain pathway and emotion regulation – culminating in high negative affect, cognitive impairments and amplification of pain suffering that defies current treatments. Our proposal seeks to develop a patient-centered, cost- effective alternative strategy – the chemosensory-based Computerized Orbitofrontal Cortex Training (CBOT-Pain) – for rapid and sustained relief of pain and negative affect through home-based noninvasive olfactory stimulation of the canonical secondary olfactory cortex (i.e., the OFC). Accomplishment of the Aims of this proposal would lead to a breakthrough product that closes the unmet need for treatment of more than 700 million people globally with chronic pain and high negative affect through (1) attenuation of chronic pain-associated OFC/PFC shrinkage, (2) rapid and sustained relief of pain and negative affect, and (3) improvement of OFC/PFC-dependent cognitive functions.